FASEB SRC on Nutrient Sensing and Metabolic Signaling

DESCRIPTION (provided by applicant): The specific aims of this FASEB science research conference are to meet to 1) present and discuss the most current work on fundamental aspects of nutrient sensing and signal transduction events in the modulation of health and disease; 2) bring together physician- scientists and research scientists in diverse research fields to promote interdisciplinary discussion and collaboration; and 3) encourage the attendance and participation of new and young scientists such as junior faculty, graduate students, and postdoctoral fellows, with special emphasis on women and under-represented minorities. Thirty-two senior investigators and up to 8 junior investigators will serve as invited speakers. Poster sessions will permit all participants to contribute, and an additional poster competition for trainees will provide special attention and recognition for their research efforts. Dr. Gerald Shulman, MD, PhD, an international expert in diabetes and endocrinology, will deliver a keynote address on cellular mechanisms of lipid-induced insulin resistance, followed by eight sessions that broadly address current issues in metabolism according to organ system or cellular signaling network. The total number of participants will be limited to 200 to encourage interaction and increase the opportunity for junior attendees to meet and discuss research with senior scientists. The five day meeting will be held August 10-15, 2014 in Big Sky, Montana.

Public health relevance
PUBLIC HEALTH RELEVANCE: This application seeks funding to support the participation of junior investigators at the 2014 FASEB science research conference on "Nutrient Sensing and Metabolic Signaling", held in Big Sky, MT on August 10-15. The main objective is to promote interdisciplinary discussion and collaboration among junior and senior physician-scientists and research scientists in fields related to obesity and diabetes.